Theoretical Models of Single Molecule Dynamics from Minimal Photon Numbers

Project Summary
Fundamental intracellular processes of immediate relevance to biomedicine–such as gene regulation and
transcription–often involve large clusters of proteins dynamically assembling and disassembling within small
diffraction-limited volumes at timescales approaching imaging data acquisition. Despite impressive μs-ms data
collection timescales achieved by many SM ﬂuorescence methods, single molecule (SM) kinetic parameters
are often instead determined from large quantities of data (millions of photons) collected and averaged over
long timescales. This compromises the temporal resolution of the data that theoretically encodes information
on events that may unfold and be resolved within ms.
Drawing insight on complex processes resolved within ms presents a profound analysis challenge. Funda-
mentally, this is because highly stochastic SMs are indirectly monitored by the equally stochastic measure-
ment output to which SMs are inextricably tied: photons. Our overall objective is therefore to develop a
framework to determine dynamical models–relevant downstream to complex intra-cellular processes–
resolved at the SM level from very limited data (i.e., time traces tens of ms or thousand of photons).
For this FTRD grant, our focus is on benchmarking our framework on simple in vitro test data sets.
To resolve these fast dynamics, we will rely on cutting-edge tools from Data Science and Statistics termed
Bayesian nonparametrics (BNPs) largely unknown to the Natural Sciences. Here we will adapt BNP tools–
some less than ﬁve years old and proposed here for the ﬁrst time for Natural Science applications–to provide
a fundamentally new treatment of data derived from confocal setups (Speciﬁc Aim I) and single molecule ﬂu-
orescence resonance energy transfer termed smFRET (Speciﬁc Aim II)–both workhorses across Biology. As
BNPs are highly ﬂexible, we develop strategies to rigorously constrain them with knowledge of the measure-
ment process, e.g., the shape of the point spread function.
For both Speciﬁc Aims, we will develop fully-integrated and unsupervised methods to resolve SM dynamical
models from ms worth of data by exploiting BNPs. In particular for Speciﬁc Aim I, we will do so starting
from single photon arrivals derived from confocal experiments. We will determine diffusive species numbers
(relevant in dealing with multimeric mixtures) as well as the diffusion coefﬁcients for each species. By resolving
diffusion coefﬁcients with the same precision as FCS from just thousands (as opposed to millions) of photons,
we could collect far shorter traces thereby dramatically minimizing sample photo-damage. Alternatively, we
could use long traces to resolve previously indeterminable quantities, e.g., diffusion coefﬁcient differences in
multimeric mixtures. For Speciﬁc Aim II we will determine quantities normally derived from current smFRET
analysis but now accounting for spectral cross-talk, label blinking and determine the number of molecular
states. Accounting for such photo-physics deeply inﬂuences our ultimate interpretation of smFRET data.

Public health relevance
Project Narrative Fundamental intracellular processes immediately relevant to biomedicine (e.g., gene regulation and transcrip- tion) often involve large and active protein clusters with dynamics occurring on short timescales approaching imaging data acquisition. Here we propose a new mathematical framework capable of unraveling fast pro- cesses down to the single molecule level from just a few milli-seconds of data. To achieve this, we adapt novel tools from Data Science and Statistics ideally suited to determine complex models from minimal, and thus uncertain, data.